Dissociable neural mechanisms of reactive versus appetitive aggression

Project Summary
Maladaptive aggression characterizes - or is comorbid with - many neuropsychiatric illnesses, and can
have devastating effects on individuals, their caretakers, and healthcare professionals. Human aggression is
typically demarcated as exhibiting either reactive (defensive) or appetitive (rewarding) components, and a
growing literature indicates they are heavily influenced by dysregulation in amygdalar or reward circuitry,
respectively. Despite a significant clinical awareness of the fundamental differences between these aggression
presentations, direct preclinical characterization of their relative circuitry and associated neuronal mechanisms
are currently absent. Therefore, the aim of my proposal is to obtain the obtain the necessary computational,
behavioral and anatomical training to identify, interrogate, and manipulate neural populations that modulate
these disparate aggressive behaviors.
This project will focus on identifying lateral septum (LS) circuit and cell-type specific mechanisms that
control of reactive versus appetitive aggression, and then further interrogate the afferent projections driving
these populations. The choice of this brain region is based on converging preliminary data, including my own,
implicating that the LS may confer opposing roles in regulating appetitive versus reactive aggression. The
circuit and cell-type specific activation of the LS will be identified using a combination of Fos (a marker of
neuronal activity) immunohistochemistry, multiplex in situ hybridization, and retrograde viral tracing. Because
of the limited temporal resolution of Fos during these behaviors, awake-behaving fiber photometry recording
will be used to observe how LS neurons encode these types of aggression in real-time. Next, the causal
significance of the LS and its afferent projections will be examined using region, circuit, and cell-type specific
optogenetic manipulations. Understanding the neural mechanisms driving these types of aggression will allow
for the development of more specific and effective treatments for maladaptive aggression presenting comorbid
with neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE Maladaptive aggression characterizes - or is comorbid with - many neuropsychiatric illnesses, and can have devastating effects on individuals, their caretakers, and healthcare professionals. Despite a long-standing knowledge of the deleterious effects of maladaptive aggression, current treatment options are largely used as pharmacological restraints rather than targeted therapies. The aim of this proposal is to seek out and establish new mechanisms underlying reactive and appetitive aggression, possibly revealing novel therapeutic targets with higher efficacy and decreased off-target effects.